Characterization of SAM gene mutation impacts on cellular processes and genome instability

Abstract
In Saccharomyces cerevisiae, Sam1, and its paralog Sam2, play roles in the methyl cycle catalyzing the
biosynthesis of AdoMet. Despite Sam1 and Sam2 having high levels of homology and findings that both proteins
localize to the cytoplasm, differences in abundance and regulation of expression speak to the differential function
and use of these proteins by the cell. In humans, three genes, MAT1A, MAT2A, and MAT2B, encode subunits
of the homologous AdoMet synthetases. These genes, and their product AdoMet, have been implicated in
multiple cancer types, but the mechanism of action is not well understood because both increases and decreases
in expression are associated with cancers. Our group has conducted studies of SAM gene dosage and
determined the impacts of changes in AdoMet synthetase genes on genome stability. SAM1 and SAM2 clearly
operate by two distinct mechanisms to impart different impacts on genome stability. This proposal contains the
next logical steps to improve our understanding of the SAM genes and impacts of changes to the methyl cycle
on cellular processes including genome stability. Through the first iteration of this grant, we have found that the
increased instability in sam2Δ/sam2Δ cells is linked to increased dNTP levels, and studies proposed here aim
to define the mechanism of increased dNTPs and how they increase recombination and breakage/NDJ events.
We also found that the increased stability in sam1Δ/sam1Δ cells is not due to increased GSH or polyamines, or
decreased ROS, and therefore hypothesize stability may come from the increased AdoMet levels in methylations
or via suppressing more reactive methyl donors. We seek to define the protective effects of increased AdoMet,
as well as changes in the proteomes of our mutants due to changes in AdoMet-dependent methyltransferase
function. We also propose studies to better understand the regulation and functionality of the Sam1 and Sam2
proteins, to provide context to the opposite effects observed due to loss of one or the other. Together, these
studies will aid our understanding of the differences in the roles of the unlinked SAM1 and SAM2 genes and how
altered expression of the homologous genes and/or changes in AdoMet levels might be implicated in disease
development and treatments. Finally, these studies will train numerous undergraduate students in hypothesis-
based research utilizing the genetically malleable yeast system ideal for teaching genetics and molecular biology
and focusing on their development as scientists and scientifically literate citizens. This proposal meets the stated
objectives of the R15 AREA program by involving undergraduate students in hypothesis driven research and
strengthening the research environment at NKU.

Public health relevance
Project Narrative The objective of the proposed research is relevant to public health because S-adenosylmethionine (AdoMet) synthetase genes and AdoMet have been implicated in multiple cancer types, but the mechanism of action is not well understood because both increases and decreases in expression are associated with cancers. Our group has conducted studies on the AdoMet synthetase genes, SAM1 and SAM2, in S. cerevisiae and determined the opposite nature of impacts of deletion of these paralogous genes on genome stability and other cellular pathways. In addition to advancing the field towards a more complete mechanistic understanding of regulation of AdoMet and a detailed characterization of the impacts of mutations; including effects on the methyl cycle and the individual steps in genome stability changes, this multi-disciplinary project meets the stated objectives of the AREA program by offering undergraduate students hands-on training in classical genetics and modern molecular techniques and strengthens the research environment at Northern Kentucky University.